Identifying and addressing bias in depression and anxiety quality measures

Summary
RFA MH-23-265 identifies a crucial need for validated outcome-focused quality measures to incentivize quality
improvement, inform consumers’ choices regarding care providers, and motivate systematic assessment of
outcomes in community practice. Quality measures based in patient-reported depression outcomes are now
included in National Committee for Quality Assurance Healthcare Effectiveness Data and Information Set
(HEDIS) “report cards” for healthcare systems and the Center for Medicare and Medicaid Services Merit-based
Incentive Payment System (MIPS) program to adjust fee-for-service Medicare payments. Similar measures
are proposed to assess and reward the quality of anxiety treatment.
While outcome-based quality measures should reward more effective care, implementation must guard against
perpetuating or exacerbating inequities. Incentives intended to be race-neutral, or even those aiming to reduce
disparities, can have inequitable consequences, penalizing those serving more Black and Hispanic patients.
Four specific aspects of existing depression measures may exacerbate inequities:
• Broad denominator definitions, including patients with widely varying treatment history and prognosis
• Preference for measures of remission rather than proportional improvement or response
• Focus on relatively narrow outcome windows as late as 12 months after initiating treatment
• Considering all observations without recorded outcome scores to be treatment failures
Data regarding current depression measures both demonstrate substantial racial and ethnic disparities and
raise concerns regarding specific design decisions that may reinforce or exacerbate inequities. While these
biases could be addressed by detailed standardization or adjustment, benefits of more complex measures
must be weighed against the value of simplicity and transparency to measurement users. We propose to use
data from 5 large health systems, including over 350,000 episodes of care for depression to evaluate biases in
existing and proposed outcome-based quality measures. Specific aims include:
Aim 1 – Identify patient characteristics that lead to lower HEDIS/MIPS quality scores for those serving more
Black and Hispanic patients by measuring to the populations they serve rather than the care they provide.
Aim 2 – Adjust quality measures to account for differences in patient populations identified in Aim 1 and
compare ranking from adjusted measures to existing HEDIS/MIPS measures.
Aim 3 – Evaluate how altering specific aspects of existing depression measures can reduce bias in
comparisons of care effectiveness without introducing unnecessary complexity.
Aim 4 – Extend analyses for Aims 1-3 to proposed outcome-focused quality measures for anxiety.
Aim 5 – In collaboration with a range of interested parties, develop proposals for improved outcome-focused
quality measures for depression and anxiety.

Public health relevance
Project Narrative Existing and proposed mental health quality measures may be biased against health systems, facilities, and clinicians serving more Black and Hispanic patients, measuring the patients they serve rather than the quality of care they provide. This research will use detailed records data from five large health systems to evaluate potential biases in existing and proposed measures and evaluate alternatives to reduce biases.